The Effects of Early Psychosocial Deprivation on Mental Health in Early Adulthood

Project Summary/Abstract
Over the past 17 years, we have conducted the first-ever randomized controlled trial (RCT) of foster care as an
alternative to institutional care for young children, the Bucharest Early Intervention Project (BEIP). We now
propose an assessment of the participants in this project at age 21 years. The new assessment period will
provide novel and important data regarding the transition to adulthood and allow us to answer timely questions
about the possibility that adolescence is a second period of marked sensitivity to environmental influences and
neural reorganization during which positive caregiving experiences may mitigate, at least in part, the negative
effects of early adversity on cognitive, emotional, and neurobiological processes as well as psychopathology.
The proposed analyses will make use of the intensive repeated assessments that have occurred beginning
when participants were infants and toddles still living in institutions, following them after randomization to care
as usual or foster care placement through childhood and adolescence. The longitudinal design is unique in
measuring multiple constructs over time spanning early, middle, and late childhood, as well as the pre-pubertal
period and the transition to adolescence. This allows us to examine whether domains of development that
were unaffected by the early intervention (e.g., Cognitive Control) may improve during adolescence among
children in stable caregiving placements, as well as whether additional improvements occur in domains that
were positively influenced by the intervention, but where children continued to show difficulties compared to
typically developing children (e.g., Reward Responsiveness). These questions will be examined not only using
behavioral data, but also in several neurobiological domains that no prior study of early adversity has assessed
over such a long period. This includes EEG, ERP, MRI, and DTI data in the neuroimaging domain, as well as
comprehensive measures of cognitive, social, and emotional functioning at every time point. Our longitudinal
RCT design with repeated assessment of caregiving relationships, psychopathology, and cognitive, emotional,
and brain development allows us to examine the joint influence of early and later caregiving experiences in
shaping a wide range of developmental processes. We will examine relations between early and later
caregiving experiences and risk for psychopathology during adolescence and early adulthood, periods
characterized by markedly elevated risk for the onset of psychiatric disorders. Our unique data allow us to
evaluate whether specific domains of cognitive, emotional, and neurobiological development “recover” or
“catch up” for children who experienced severe early deprivation followed by stable caregiving in adolescence.
We will also assess the effects of early adversity and positive caregiving experiences on the emergence of
developmentally appropriate competencies during young adulthood. Determining the relevance of adolescent
caregiving experiences in shaping psychopathology in emerging adulthood is essential to designing
interventions that have the potential to buffer the effects of early adversity in the US and worldwide.

Public health relevance
Project Narrative In this competing renewal we build on a unique randomized controlled trial of foster care as an alternative for institutional care based in Bucharest, Romania. This valuable sample of children will be studied when participants are 21 years of age when we will examine the long-term consequences of early adversity and early intervention, as well as the effects of positive caregiving during adolescence on brain development, psychopathology, and competent functioning in young adulthood. This unique longitudinal design provides an opportunity to examine whether adolescence is a second window of sensitivity to environmental influences that allows for meaningful brain reorganization for youths in positive environments in ways that may mitigate some of the long-term consequences of early adversity.